Project I: Discovery and Evaluation of Antibodies and Cocktails

Abstract – Project I
The overarching goal of the Prometheus consortium is to develop antibody-based prophylactics and
therapeutics against three major groups of Category A priority viruses that pose the highest risk to
national security and public health and cause zoonotic disease—ebolaviruses, the nairovirus Crimean-Congo
hemorrhagic fever virus (CCHFV), the New-World hantaviruses Andes virus (ANDV) and Sin Nombre virus
(SNV), and the Old-World hantavirus Puumula virus (PUUV). No approved treatments are available for any of
these viruses. Given the safety and efficacy of over 50 mAb-based therapies currently available in market for
various diseases, mAbs are a low-risk platform to develop countermeasures for these Category A viruses. The
rapid discovery and development of large numbers of pathogen-specific human monoclonal antibodies (mAbs)
from convalescent and acutely infected donors is the central strength to our platform. Coming from hosts who
have already mounted an effective antibody response, these naturally occurring mAbs are less likely to elicit
tissue cross-reactivity and in vivo toxicity in humans and also obviate the need for chimerization or time-
consuming humanization. Prometheus will use these mAbs as raw material to produce broadly protective
immunotherapeutics that (i) are robust to natural viral genotypic variation; (ii) leverage multi-epitope targeting
and an innovative feature we term RAVE (reciprocal antagonism to viral escape) to enhance potency and resist
escape of viral neutralization; (iii) exploit tuned Fc effector properties for extended in vivo half-life and more
effective elimination of viral particles and infected cells; and (iv) can be directly and rapidly transitioned to
advanced pre-clinical development. Project I will work collaboratively with Project II to identify human mAbs
and oligoclonal mAb cocktails against CCHFV and hantaviruses (SNV, ANDV, and PUUV) with these
properties—pan-ebolavirus lead human mAbs have already been identified by Prometheus members. We will
hand off lead mAbs and cocktails to Core B as candidates for advanced development of therapeutics, and to
Project III for studies aimed at the generation of DNA-encoded mAbs (DMAbs) for prophylactic delivery. In
consultation with the SAC, lead molecules will be evaluated by Core C for protective efficacy in NHP models
of CCHFV and SNV challenge.

Public health relevance
Narrative – Project I No FDA-approved treatments exist for medically important and globally prevalent human viruses such as ebolaviruses, Crimean-Congo hemorrhagic fever virus (CCHFV) and hantaviruses. Projects I will work collaboratively with Project II to isolate highly potent antibodies against CCHFV and hantaviruses from human survivors of these deadly virus infections; antibodies against ebolaviruses have already been identified by Prometheus members. We will hand over the best antibodies to Core C to test in animal models and to further develop them for antiviral therapy for delivery as antibodies (Core B) or DNA (Project III).